CASP-11-dependent RNA modifications and their Role in Multi-Organ Pathologies

Project 3: Host and viral RNA modifications and their roles in multi-organ pathologies
Abstract
The continuous emergence of SARS-CoV-2 variants of concern (VoC) and antibody and drug-escaping mutants
complicates the current COVID-19 pandemic. There is an urgent need to develop new improved antiviral
therapies for COVID-19. RNA modification is a widespread post-translational modification of RNA that regulates
numerous biological processes including RNA metabolism, protein translation, gene expression, and innate and
adaptive immune responses. Currently, the roles of these RNA modifications and their modifying enzymes in
SARS-CoV-2 replication, innate immunity, and pathogenesis are largely unknown. Project 3 is built upon our
recent finding that inhibition of several major RNA modifying enzymes decreases SARS-CoV-2 replication and
lung pathology in vitro and in vivo and that inhibition of caspase-4/11 (CASP11) blocks the root cause of SARS-
CoV-2-induced cytokine storm and multi-organ pathology (Projects 1 and 2). These data leads to our hypothesis
that inhibition of both RNA modifying enzymes and CASP11 will be an improved therapeutic strategy. The goals
of Project 3 are to determine the roles of major RNA modifications in modulating SARS-CoV-2 replication, innate
immunity, and pathogenesis, to understand the interplay between CASP4/11 and RNA modifying enzymes, and
to develop new improved antiviral therapies by synergistic targeting CASP11 and RNA modifications. In Aim 1,
we will use high-throughput RNA sequencing techniques to precisely map major RNA modifications including
N6-methyladenosine (m6A), 5-methylcytosine (m5C) 2’-O-methylation (Nm), pseudouridine (Ψ), N7-
methylguanosine (m7G), and N1-methyladenosine (m1A) in SARS-CoV-2 and host RNAs purified from COVID-
19 patients and virus-infected ex vivo primary well-differentiated human bronchial epithelial cultures (hBEC) and
we will determine the roles of these RNA modifying enzymes in SARS-CoV-2 replication, innate immune
response, and pathogenesis in vitro and in vivo. In Aim 2, we will determine whether inhibition of RNA modifying
enzymes and CASP11 provides synergistic therapeutic effects against SARS-CoV-2 infection. We will first
determine the interplay between CASP11 and RNA modifications during SARS-CoV-2 infection. CASP11 and
specific RNA modifying enzymes will be knocked out together in hBEC and mice. The impact of double knockouts
on SARS-CoV-2 replication, innate immunity, and pathogenesis will be determined. Finally, we will determine
the anti-SARS-CoV-2 activity of a panel of small molecule inhibitors or shRNA-nanoparticles targeting RNA
modifying enzymes in vitro and in vivo. The most potent inhibitor will be chosen to combine with the most effective
CASP11 inhibitor, and we will determine whether their combination provides synergistic therapeutic effects
against COVID-19 disease. The successful outcome of Project 3 will not only fill a major gap in our
understanding of the roles of RNA modifications and CASP11 in viral replication, innate immunity, and
pathogenesis but also facilitate the development of novel, improved therapeutic strategies against SARS-
CoV-2 infection by targeting RNA modifications and CASP11.